CE23-003 - A multi-level examination of social safety net accessibility as a modifiable structural condition contributing to violence against children

Project Summary/Abstract:
Violence is a common, costly, and preventable cause of morbidity and mortality for children in the United
States. Violence against children occurs more frequently for children who grow up in poverty. The primary
method of addressing poverty in the U.S. is the provision of social services. Yet, these safety net services
underserve the communities that are the most in need of them. This mismatch between safety net need and
accessibility is a structural condition that may be a social determinant of health related to violence against
children. Rigorous research, such as causal effects study designs, is needed to identify modifiable community-
level factors for targeted prevention. The proposed Career Development Award (K01) research goal is to
evaluate the relationship between the community safety net accessibility, the primary method of alleviating
poverty, and violence against children. The proposed study leverages population-based, longitudinal data from
multiple sources, including novel linked administrative data and detailed census-tract-level data on social
service availability. The proposed research activities will address the following specific aims: 1) determine, at
the community level, if neighborhood safety net accessibility is related to violence against children indicators
(child protection reports, child protection placements, violence-related medical encounters, and violence-
related deaths); and 2) quantify, at the child-level, the causal impact of community safety net accessibility on
violence-related mortality through the duration of childhood. To pursue these aims, the PI will receive training
in rigorous causal effects study design and cross-cutting violence prevention research under the mentorship of
national leaders in these areas. The proposed research study addresses the important research priority for the
CDC’s National Center for Injury Prevention and Control of the relationship between community conditions and
violence against children using an innovative approach with a strong scientific premise. Completion of the
training and research activities will allow the PI to become an independent researcher who produces high-
impact research that can be used in the development of prevention programming and to better explain the
structural conditions that contribute to violence against children.

Public health relevance
Project Narrative The overall goals of the proposed Career Development Award (K01) are relevant to public health because it evaluates the relationship between community conditions and multiple forms of violence against children, an area with limited research but a strong scientific premise. Rigorous evidence regarding this relationship can be instrumental to better understanding violence against children and in the development of effective prevention strategies. Thus, the proposed project is relevant to the CDC Injury Center’s Research Priority of reducing and preventing the interpersonal violence that impacts children and youth.